IGF::OT::IGF A SHARED DECISION-MAKING TOOL TO PREVENT SUBSTANCE ABUSE. N43DA-15-2246. PERIOD OF PERFORMANCE: SEPTEMBER 15, 2015 - MARCH 14, 2016. BASE AWARD.

The long term goal of this project is to reduce substance abuse by making evidence-based practices, such as the SBIRT practice, more accessible and more effective in primary care settings. The mobile app-based intervention complements standard SBIRT practice.